Impact of microfibril turnover on vascular development and disease

SUMMARY
Dominant FBN1 mutations cause Marfan syndrome, an inherited human connective tissue disorder affecting
fibrillin-1 microfibrils and leading to thoracic aortic aneurysms with risk of aortic dissection and rupture. Fibrillin-
1 is a product of vascular smooth muscle cells (VSMC), which provides an important link in the mechanical
continuum from the SMC contractile cytoskeleton to the extracellular matrix, in addition to providing a template
for elastic fiber assembly. Reduced tissue fibrillin-1 content as a result of FBN1 haploinsufficiency is thought to
be the mechanism underlying a significant proportion (over 1/3) of Marfan syndrome mutations.
In recent work we found that ADAMTS6, a metalloprotease secreted by VSMC, cleaves both fibrillin-1 and
fibrillin-2. The latter is produced primarily during the embryonic period and is thought to have a minor role in the
aorta after birth. Analysis of a mouse Adamts6 null mutant, which does not survive past birth, shows an
accumulation of both fibrillin-1 and fibrillin-2, with major skeletal and cardiac defects we have genetically
attributed to fibrillin-2 accumulation. Thus, ADAMTS6 appears to be a major protease regulating fibrillin microfibril
turnover. This provides a compelling rationale for targeting ADAMTS6 in Marfan syndrome in a novel disease-
modifying approach.
Based on these findings, the overarching hypothesis of this proposal is that ADAMTS6 inactivation in vascular
smooth muscle cells postnatally will protect aortic fibrillin-1 microfibrils from proteolytic turnover, thus increasing
microfibril abundance and mitigating aortic aneurysm growth and dissection in Marfan syndrome. In Aim 1, we
will use a new Adamts6 conditional mutant to test this hypothesis through conditional deletion of Adamts6 in
VSMCs in a well-characterized mouse model of severe Marfan syndrome that reliably progresses to dissection
and rupture. In Aim 2, we will define the intermolecular interaction of fibrillin-1 and ADAMTS6 to identify the
major molecular determinants of proteolysis. In vitro microfibril assembly will be used to test the impact of
blocking ADAMTS6-fibrillin interactions. These experiments will inform future approaches for protecting
microfibrils from ADAMTS6-mediated turnover.
Impact: A disease-modifying approach for Marfan syndrome does not exists, and non-surgical options have not
been wholly effective in preventing dissection. These aims leverage our initial discovery that ADAMTS6 cleaves
fibrillin-1 for continued investigations intended to drive development of an ADAMTS6 blockade-based disease-
modifying approach for Marfan syndrome. Specifically, the disease mechanism in many patients is reduction of
fibrillin-1 microfibrils and we aim to enhance microfibril abundance by protecting them from breakdown. Together
the aims provide a proof of principle for a possible disease-modifying therapy (Aim 1) and the basis for interfering
with ADAMTS6 cleavage of fibrillin-1 (Aim 2). The work proposed herein also addresses fundamental questions
of how fibrillin-1 is turned over in the vascular wall.

Public health relevance
NARRATIVE FBN1 is the causative gene for Marfan syndrome, an inherited disorder of fibrillin-1 microfibrils leading to progressive thoracic aortic aneurysm and an elevated risk for aortic dissection and rupture. Based on our recent discovery that the protease ADAMTS6 binds to and cleaves fibrillin-1, and thus regulates microfibril abundance, we will test whether preventing ADAMTS6 cleavage of fibrillin-1 in Marfan syndrome will protect microfibrils from degradation. The clinical promise of this research is that enhancing microfibril abundance by specific targeting of ADAMTS6 in the aortic wall may protect against aortic aneurysm progression or dissection in patients with Marfan syndrome as a novel disease-modifying approach.